Promoting Diversity in Health-Related Research

ABSTRACT FROM PARENT PROJECT (Image Guided Programming: Pediatric Speech,
Language and Literacy)
Although the recent literature has indicated that children receiving cochlear implants often have
dramatically improved speech and language ability relative to previous generations of children
with hearing loss, many pediatric cochlear implant (CI) patients display persistent speech and
language disorders despite early implantation and associated speech/language intervention
[see (1,2)]. There is a striking paucity and ongoing need for studies that systematically examine
the relationship between surgical implantation parameters, audiological profile, and subsequent
speech, language, and literacy outcomes in pediatric CI [see (3)]. The proposed project
provides a unique opportunity to examine whether individualized, image-guided CI
programming (IGCIP) significantly improves outcomes in pediatric CI patients. The proposed
research is a collaboration between an audiologist (Gifford) and a speech language pathologist
(Camarata) and a biostatistician (Dietrich). The proposed research activities will examine the
impact of personalized IGCIP in pediatric patients on measures of basic auditory function
(spectral and temporal resolution), speech recognition, speech production, language, and
measures of preliteracy and reading comprehension using a randomized wait-list control
treatment design. A total of 60 children with CIs aged six to twelve years old will be enrolled in
the project and one-half (n = 30) will be randomized to an immediate IGCIP condition and half to
a 12 month waitlist control condition. The waitlisted participants (n = 30) will undergo IGCIP
after 12 months of monitoring and followed up for an additional 12 months after the
programming has been provided (total time in the study: 24 months). Those immediately
provided with IGCIP will also be enrolled for a total of 24 months. All participants will undergo
extensive audiological and speech and language assessments in addition to comprehensive
audiological assessment at baseline as well as at regular intervals: 2, 6, 12, 14, 18, and 24
months. We will use predictor analyses to determine the impact of immediate and deferred
IGCIP on subsequent auditory, speech, language, and literacy outcomes.